Role of Nicotinamide Nucleotide Adenylyltransferase-1 (NMNAT1) in Chromatin Remodeling and Gene Regulation

PROJECT SUMMARY
Chromatin remodeling and gene expression are highly dynamic processes in the nucleus. The regulation of
these processes is crucial to maintain proper cellular functions. Chromatin remodeling enzymes mediate
changes in chromatin structure and control the cycling of chromatin-associated factors on and off the genome.
The remodeling of chromatin depends on metabolites (e.g., ATP and NAD+), which fuels chromatin remodeling
enzymes activity. NMNAT1 is a metabolic enzyme primarily involved in the local production of NAD+ in the
nucleus. NMNAT1 is thought to provide pools of NAD+ which fuels NAD+-dependent chromatin remodeling
enzymes, including SIRT1 and PARP1. However, various studies suggest that NMNAT1 may also allosterically
regulate these enzymes activity in an enzymatic independent manner. Nonetheless, the role of NMNAT1 in
regulating chromatin remodeling and gene expression through local NAD+ production and interactions with
chromatin remodeling enzymes remains poorly defined. In this proposal, I seek to define the role of NMNAT1 in
regulating chromatin remodeling enzymes activity, chromatin structure, and gene expression. I hypothesize that
the cycling of NMNAT1 on the genome produces local NAD+ gradients that regulate chromatin-modifying
enzyme activity, influencing rapid changes in chromatin structure and gene expression of target genes. To
address this hypothesis, I will (1) establish an NMNAT1 knock-out cellular system to perform structure-function
studies in live cells and identify phenotypical defects upon depletion of NMNAT1. To validate this system, I will
perform rescue experiments with wild-type NMNAT1 and catalytic dead mutant NMNAT1. (2) Examine how
NMNAT1 regulates the expression of chromatin remodeling enzymes (e.g., SIRT1) target genes by defining
changes in chromatin structure, gene expression and genomic occupancy, and (3) establish how NMNAT1
cycling dynamics regulate chromatin remodelers and transcriptional bursting. These studies will be essential to
determine how nuclear metabolic enzymes like NMNAT1 and metabolite production regulate chromatin structure
and gene expression of target genes. This knowledge will define new paradigms regarding gene expression and
regulation. Under the mentorship of Drs. Robert Coleman and Robert H. Singer, Yessenia Cedeno Cedeno will
receive multi-disciplinary training in molecular and cellular biology combined with expertise in state-of-the-art
microscopy. This will allow Yessenia to successfully execute the proposed research and training plans and
advance her professional career as an independent scientist.

Public health relevance
PROJECT NARRATIVE This proposal aims to define how NMNAT1 as an NAD+ synthetase provides NAD+ to fuel chromatin remodeling enzyme activities to regulate chromatin structure and gene expression dynamics. Impairments in regulating these processes lead to a significant number of human pathologies, including cancer and age- related diseases. Therefore, understanding the functions of NMNAT1 as a nuclear metabolic enzyme in regulating chromatin remodeling and gene expression is crucial to define new paradigms regarding gene expression and regulation.